The role of macrophages in weight loss-induced metabolic health and adipose tissue inflammation resolution

PROJECT SUMMARY
Inflammation is at the center of many obesity complications, such as diabetes and heart disease. The most
recommended treatment for obesity is weight loss, which results in decrease of the related inflammation
and complications, making weight loss a very attractive therapeutic strategy. However, the mechanisms by
which weight loss benefits obesity-related inflammation is unknown, representing a major knowledge gap.
We recently revealed that in mice, weight loss induced by caloric restriction (CR) promotes resolution
of inflammation in atherosclerotic cardiovascular disease. Mechanistically, this is attributed to a new
macrophage subtype (termed CR-macrophages) that have increased capability to efferocytose (the
phagocytic process by which macrophages clear apoptotic cells) and accumulate mostly in visceral adipose
tissue, but also in atherosclerotic plaques. CR-macrophages are distinguishable by their high expression
of CD16a, which our data demonstrate is required for their higher efferocytic activity. Therefore, our central
hypothesis is that weight loss induces a pro-resolving phenotype in macrophages that subsequently
resolves inflammation and improves metabolic health. In the first aim we will determine visceral and
subcutaneous adipose tissue macrophage phenotype, function and transcriptome across species (mouse
and human) and time of weight loss. Aim 2 will use several strategies, including cell therapy and
nanomedicine, to test whether CR-macrophages can be used to treat metabolic dysfunction in obese mice.
Our results will unearth novel immunological pathways underlying weight loss-induced inflammation
resolution that will suggest new strategies for the treatment of obesity complications, establishing a new
paradigm in obesity management.

Public health relevance
PROJECT NARRATIVE It is well known that weight loss is one of the most effective ways to reduce and reverse obesity complications, but we do not understand the underlying reasons. In this project we will test whether specific immune cells called macrophages, which are normally important to engulf and clear microbes and dead cells, are responsible for the health benefits seen with weight loss. Our results will suggest new strategies for the treatment of obesity-related diseases.